Re-entry Supplement associated with R01AG08073

PROJECT SUMMARY
During early stages of Alzheimer’s Disease (AD), skeletal muscle mass and function precipitously declines in
comparison to those who are cognitively intact, potentially due to poor neuromuscular health. Thus, bioenergetics
of peripheral tissues may have an underappreciated role in AD etiology. Exercise is an effective means to
promote mitochondrial and neuromuscular health. However, whether regular exercise has therapeutic potential
for delaying or preventing AD is an outstanding question. Thus far, we have shown in 5xFAD mice, a model of
AD, neuromuscular dysfunction is present at a young age before observable cognitive decline and that muscle
mitochondrial respiration does not improve following 12 weeks exercise training in 22-week-old 5xFAD mice
compared to WT. In sum, impaired neuromuscular function may underlie a maladaptive bioenergetic response
to exercise prior to overt manifestation of AD-like pathology. There is a critical need therefore to define adaptive
neuromuscular mechanisms in relation to established neuropathological changes over the continuum of AD-like
pathology to identify novel therapeutic targets. To that end, we generated preliminary data demonstrating that
treatment with the acetylcholinesterase inhibitor Donepezil before neuromuscular impairment, was sufficient to
delay onset of declines in nerve-stimulated muscle torque and compound sciatic nerve action potential (CNAP)
in 5xFAD mice. Thus, our central hypothesis is that combining DPZ with exercise training will normalize the
adaptive response of skeletal muscle to exercise, improving mitochondrial quality through delay of AD-related
neuromuscular degeneration. We propose one aim: Aim 1) Determine neuromuscular adaptive response to
endurance exercise training in AD mice before AD-like pathology. 1a. To investigate the influence of DPZ on
mitochondrial quality following endurance exercise training I will assess mitochondrial respiration, reactive
oxygen species (ROS) production (via Oroboros O2K), as well as synthesis (i.e. biogenesis) and breakdown (via
D2O labeling - GC/MS) of muscle mitochondria in 5xFAD male and female mice following 12 weeks voluntary
wheel running with or without DPZ in comparison to sedentary controls. 1b. To assess the combined impact of
exercise and DPZ on neuromuscular function I will assess pre- and post-exercise training and DPZ treatment
muscle function in vivo (Aurora), exercise capacity and substrate utilization (CLAMs), body composition (NMR),
NMJ integrity (histology and confocal microscopy) and compound nerve action potential (CNAP) of sciatic nerve.
This supplement will bolster and expand upon the associated funded award (R01AG057825) by introducing a
clinically employed pharmaceutical treatment (Donepezil). Anticipated discoveries are anticipated to further the
development of targeted translational strategies related to novel identification of risk, as well as prevention and
treatment of AD.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will advance mechanistic understanding of neuromuscular adaptation to exercise and Donepezil in relevant AD mouse model. The project is relevant to NIA’s mission because it focuses on the molecular and physiological response of skeletal muscle mitochondria and motor nerves in the context of AD neuropathology that indicates a maladaptive bioenergetic response to exercise, which may elucidate an integrated mechanism that will take into account the system-dependent nuance of bioenergetic dysregulation in AD etiology. Scientific and professional development opportunities will provide a foundation for successful reentry to academic research by helping to establish an independent research program focused on mechanisms of age-related disease and healthy aging.